Multi-site Community Oncology Planning for the CONNECT Intervention Targeting Lung Cancer Caregivers

Project Summary
Our team has demonstrated availability of evidence-based supportive care services in community oncology to
support informal (unpaid/ family) caregivers in caring for themselves and their care recipient undergoing cancer
treatment (e.g., psychosocial support, self-care/ wellness classes, medical task training), but connection to
these services is abysmal. A scalable and systematic process is critically needed to identify caregiver needs
and connect caregivers with services. This may be especially valuable for lung cancer caregivers who report
exceptional supportive care needs and high levels of caregiver burden. We previously demonstrated strong
feasibility and acceptability of Caregiver Oncology Needs Evaluation Tool (CONNECT) in a pilot randomized
clinical trial with 40 lung cancer caregivers at one academic medical center. We also observed significant
improvements in caregiver burden and a clinically significant decrease in depression in the intervention group
relative to control group. We propose in this next step of multi-site intervention planning, to also include
navigation to address barriers that may hamper caregiver supportive care use. The overall goal of this program
of research is to develop innovative and scalable programs to improve supportive care delivery for cancer
caregivers in the community. In this application, we propose to gather essential data for a future multi-site
efficacy trial of CONNECT in collaboration with the Wake Forest NCI Community Oncology Research Program
Research Base (WF NCORP RB) and key stakeholders. For Aim 1, we will survey NCORP sites to determine
outpatient oncology practice (N=60) interest and capacity to test the CONNECT Intervention across the broad
NCORP network. For Aim 2 and Aim 3, we will conduct a multi-site randomized pilot trial. For Aim 2, we will
assess the multi-site feasibility (accrual, participation, and retention) of the CONNECT Intervention enrolling
120 lung cancer caregiver-patient dyads (CONNECT, n=40; Standard Care, n=40; Generic Resource List,
n=40) with the goal of informing methods for the future trial. For Aim 3, we will obtain preliminary data on site
training needs, time needed for site participation, and communication processes between participating sites
and study personnel to optimize multi-site intervention delivery in the future fully powered trial. Pending
demonstration of feasibility, we will conduct a future fully powered efficacy trial using the NCORP network.

Public health relevance
Project Narrative Caregiver Oncology Needs Evaluation Tool (CONNECT) empowers and educates caregivers about the benefits of supportive care services and systematically identifies unmet needs to connect lung cancer caregivers with a tailored list of supportive care resources. The intervention offers a scalable approach to reach a large number of lung caregivers, including vulnerable caregivers with barriers to in-person participation. Use of the NCI Community Oncology Research Program (NCORP) to plan for and pilot test this intervention will support future trial efficiency and yield findings generalizable to diverse caregivers, patients, and community oncology settings.